CRYSTALLOGRAPHY OF RIBOSOMES MAD PHASING

We are interested to run experiments on station 1-5AD in order to test the feasibility of MAD and MASC (multi-wavelength anomalous solvent contrast) experiments for ribosomal crystals. If successful, we will collect the anomalous data.